Enrichment Program

Project Summary – Enrichment Program
The Enrichment Program of the Nutrition Obesity Research Center (NORC) at the University of North Carolina
at Chapel Hill (UNC) is designed to foster the exchange of knowledge and ideas among faculty members,
trainees, research staff, and the community at large while increasing the general public’s awareness of
nutrition and obesity research at UNC and beyond. These activities span basic science, epidemiologic
research, intervention research, translational science, and nutrition- and obesity-relevant community
engagement and policy. Activities include but are not limited to seminars, workshops, symposia for a variety of
audiences, as well as nutrition education for physicians. The goals of the Enrichment Program are to create an
engaging educational program to foster interdisciplinary collaborations, to provide training opportunities to
foster the development of early career investigators and investigators from underrepresented minority
investigators, and to educate the general public about the UNC NORC and the importance of nutrition and
obesity research.